Synthetic DNA-launched and adjuvanted Env immunogens for HIV

Overall Summary
A protective vaccine for HIV is arguably the most important prevention strategy to end the global HIV pandemic.
The RV144 trial demonstrated a correlation between protection and envelope (Env) specific serum IgG
antibodies. However, there was a notable lack of HIV-specific neutralizing antibodies (nAbs) and T cell
responses. The DNA platform has several advantages, it is (1) simple to design, (2) can co-deliver molecular
adjuvants, (3) can deliver complex structural antigens, and (4) is safe and well tolerated, even after numerous
boosts. In our previous IPCAVD program we developed DNA-launched nanoparticle (DLNP) vaccines targeting
Env which induced potent and neutralizing immunity in vivo. We have also developed DNA-launched native-like
trimer (DL-NLT) immunogens including the clinically relevant BG505 MD39 trimer (Xu et al. Nat. Comm 2022).
Protein nanoparticles are difficult to manufacture and poorly stimulate CD8+ T cells. We reported that in vivo
assembled nanoparticles drive extremely rapid and strong B and T cell immunity. Functional antibody responses
require help from germinal center (GC) follicular helper T cells (TFH). In previous clinical trials with HIV antigens,
we observed increased B and T cell responses in the presence of plasmid-encoded IL-12 (pIL-12). Work from
members of this team has demonstrated that co-delivery of adenosine deaminase (ADA-1) and plasmid-encoded
IL-21 (pIL-21) can enhance antibody induction in mice in a GC-dependent fashion. Here, we combine the DLNP
and DL-NLT platforms to generate DNLPs bearing stabilized NLTs focusing immune responses on apex and
CD4bs B cell lineage-targeting Envs (DNLP-ACE). We will characterize humoral and cellular immunity to these
constructs in the presence of molecular IL-12 with and without additional GC-targeting adjuvants, in mouse and
non-human primate vaccination studies. The overarching hypothesis of this project is that DLNP-ACE
immunogen technology combined with the co-delivery of genetic adjuvants is a novel approach for the
development of HIV-1 vaccines that promotes robust, durable, broad, and neutralizing antibody
responses, and supports effector T cell function in vivo A key innovation of this project will be to integrate
the selected DNLP-ACE HIV vaccine constructs in a dual expressing plasmid construct with next generation
noninvasive intradermal skin electroporation (EP) devices which promote functional CTL and humoral immune
responses. The clinical development plan for this IPCAVD is directed by a leading HIV vaccine development
organization, Inovio Pharmaceuticals (INO), which has expertise in development of synthetic DNA vaccines and
in vivo electroporation delivery. Inovio will oversee clinical grade production of 2 plasmid constructs at a state-
of-the-art cGMP plasmid manufacturing facility. Inovio’s processes have passed rigorous international regulatory
reviews and have been used in dozens of human clinical trials in the U.S., Europe and Asia, including multiple
Phase II and in Phase III studies.

Public health relevance
Overall Narrative Building on progress from our previous IPCAVD, the goal of this program is to advance DNA launched nanoparticles bearing native like trimers which focus immune responses on apex and CD4bs B cell lineage targeted Envs (DLNP-ACE). Combining these novel immunogens with DNA- delivered genetic adjuvants to support vaccine-induced immunity represents a great leap forward in the design of HIV-1 vaccines. We have assembled an innovative team of experts in HIV vaccine immunogen design, DNA vaccine delivery, immune analysis, and infection models, and combined them with a clinical program partner, Inovio pharmaceuticals, which has extensive experience in cGMP production and clinical translation of DNA products.